Targeting intracellular trafficking for cancer therapy

PROJECT SUMMARY/ABSTRACT
My long-term goal is to lead a translational cancer research lab at a major research institution. Throughout my
predoctoral work, I have cultivated expertise in studying intracellular trafficking in multiple contexts including
cancer metabolism, phosphatase signaling, and nucleotide-based drug delivery. My overall objective in this
application is to complete my ongoing studies and then leverage my experience studying endolysosomal
trafficking to address critical open questions in cancer immunology during my postdoctoral work. For the F99
phase, I will complete studies evaluating small molecules that target intracellular trafficking as antisense
oligonucleotide (ASO) potentiating agents in tumors and normal tissues. ASO are 16-20 bp nuclease-resistant
oligonucleotides that base pair with a target RNA and can elicit its degradation or alter its splicing. Therefore,
ASO are the ultimate platform technology that could cripple lethal, drug-resistant tumors by targeting
“undruggable” oncogenes. Poor uptake into tumor cells currently limits the clinical use of ASO in cancer
patients. By bringing a cell biology background to this field, which is populated primarily by biochemists, I have
identified 4 novel proteins that when targeted increase ASO activity by an unprecedented 100-fold. For the K00
phase, I will continue to study endolysosomal trafficking, but shift my focus from ASO delivery to resistance
mechanisms to cancer immunotherapies. The rationale underlying the proposed training plan is that the critical
trafficking steps necessary to deliver ASO to the cytoplasm of tumor cells have also been implicated in anti-
tumor immunity. Combining my expertise in intracellular trafficking and technical skills in advanced imaging
with deep knowledge gained from working in a cancer immunology lab is likely to produce significant advances
in this field. Completing these studies will also allow for me to develop a niche in this highly competitive field
that I could expand upon in my own independent research lab.
The overall training objective in this application is to develop and cultivate the management, networking,
immunology expertise, and writing skills that are necessary to be successful in a postdoctoral fellowship and as
an academic PI at a major research institution. The Training Plan addresses these training goals by taking
advantage of critical resources provided by UCI and its vibrant, collaborative cancer research community.

Public health relevance
Project Narrative/Relevance The proposed research is relevant to public health because it focuses on increasing the efficacy of powerful therapeutics that have the potential to cripple late-stage, drug resistant tumors. Thus, the proposed research is relevant to the NIH's mission to enhance human health, lengthen life, and reduce illness.